Selection of the B Cell Repertoire in Senescence

? DESCRIPTION (provided by applicant): In old age, in both mice and humans, B lymphopoiesis is compromised and intrinsic B cell defects contribute to poor Ig isotype switch and somatic hypermutation. Old age causes poor B lymphopoiesis by interfering with: 1) pro-B/pre-B cell function; 2) development of common lymphoid progenitors (CLP); and 3) maintenance of lymphoid-biased hematopoietic stem cells (L-HSC). This contributes to alterations in B cell numbers and composition in the periphery and also changes the read-out of B cell antibody specificities. The latter can result in poor protection to infectious diseases. cells in old mice (and humans) are pro-inflammatory and express TNFa. In particular, the Age-associated B cells (ABC) in old mice are pro-inflammatory and represent a novel B cell subset which expands extensively in old age. By 2 years of age, ABC can constitute up to one- half of mature B cells in spleen and bone marrow. In old mice, TNFa diminishes peripheral B cell function by interfering with Ig isotype switching. In the bone marrow of old mice, ABC, via TNFa, induce apoptosis in B cell precursors. Moreover, those B cell precursors which are less affected by ABC in old mice express lower levels of the surrogate light chain (SLC). The SLC is a key constituent of the pre-B cell receptor (preBCR); compromise of the preBCR in old mice affects the read-out of the B cell antibody repertoire. This is seen as an increased frequency of B cells which are reactive with the bacterial epitope phosphorylcholine, are negative for the T15 idiotype, and are of low affinity. These old-age related anti-PC B cells produce less protective antibodies to pneumococci. In this proposal, we will test the role of pro-inflammatory B cells, including ABC, in down-regulating B lymphopoiesis at relatively late stages (pro-B/pre-B) as well as early stages (Common Lymphoid Progenitors [CLP]; hematopoietic stem cells [HSC]) of development (Specific Aims 1 and 2). Furthermore, we will determine effects of pro-inflammatory B cells, including ABC, in both altering the read- out of the B cell repertoire and inhibiting Ig isotype switch and somatic hypermutation in mature B cells (Specific Aim 3). Finally, we will test whether depletion of pro-inflammatory B cells and their subsets in old mice rejuvenates B cell development and repairs the functional B cell deficiencies seen in old age.

Public health relevance
PUBLIC HEALTH RELEVANCE: In old mice and humans, antibody responses to infection are often of low quantity and poor quality. In addition, the generation of new B lymphocytes, the cells that produce antibodies, is reduced in old age. In this proposal, we will investigate a novel role for B cells themselves in causing inflammation that negatively "feeds back" on B cell generation and functions in old mice. We will define the mechanisms by which old inflammatory B cells cause these deficiencies in old mice and whether depletion of old B inflammatory B cells "rejuvenates" the production of protective antibodies against infection.